Hormones: Molecular Mechanism of Action and Functions

Project Summary/Abstract
The long standing goals of this training grant are to provide support and training to academically strong and
highly motivated predoctoral and postdoctoral researchers in the field of endocrinology and related subjects
dealing with all aspects of hormone biology at the organ, cellular, molecular levels through modern genetic
tools in various model organisms. We aim to provide our trainees with a broad intellectual background that
includes coursework, experimental expertise, seminars, grant craftsmanship and career advice. The program
is implemented by our outstanding training faculty and the rich research infrastructure at Columbia University.
The training faculty are highly collaborative and national and international leaders in research exploring the
mechanisms of steroid, retinoid, thyroid and polypeptide hormones as well as the paracrine interactions
associated with growth factors, cytokines and important signaling transduction pathways and inter-organ
communications. The trainees can work in diverse experimental systems across model organisms and human
subjects. We continually update our training faculty to reflect the evolving trends in research in endocrinology
and the changing Columbia faculty base. This training program has been in effect for 42 years and the
accomplishments of our trainees during this time have been outstanding, with many of them currently holding
NIH funded tenure track faculty positions in premier academic institutions. During the past cycle (2015-2019),
A total of 19 unique trainees have been supported or are currently being supported by the training grant. The
recently funded trainees have all been extremely productive in their research programs. All previous trainees
continue to pursue science related careers. Most of our postdoctoral fellows have attained individual research
grants. We continue to work with our fellows to help them achieve success in their current and future research
careers. Overall, the training program emphasizes excellence in scholarship and research and career
advising. In addition, participation in the program exposes trainees from diverse disciplines to practical
applications in endocrinology and highlights translational aspects of their research. Due to the steadily
increasing demand for training grant slots, we are requesting additional positions to accommodate our highly
qualified pool of applicants.

Public health relevance
Project Narrative The goal of this training grant is to provide support and specialized training to highly motivated predoctoral and postdoctoral researchers in the field of endocrinology and related subjects dealing with all aspects of hormone biology at the organ, cellular, molecular levels using modern genetic tools in various model organisms and human subjects. The program capitalizes on the outstanding environment of 30 basic and clinical science researchers representing seven Columbia University departments.